The Atlantic Health Cancer Consortium Community Oncology Research Program (AHCC Corp)

As the first NCORP Community Site in the state, AHCC CORP serves three-quarters of the New Jersey population. AHCC CORP expands the NCORP network by 6.5M people, advancing the state of the science in cancer prevention, control, screening, care delivery research, and precision medicine studies through biospecimen collection, as well as providing critical access to treatment and imaging studies conducted by the National Clinical Trials Network. With a higher cancer incidence rate than the US as a whole, New Jersey is an important area for cancer prevention and control research.
Atlantic Health Cancer Consortium Community Oncology Research Program (AHCC-CORP) is the first NCORP Community Site within the state of New Jersey and combines the collective strengths of world-class healthcare systems with community oncology care delivery. AHCC-CORP covers a geographically diverse area representing 73% of New Jersey’s population. AHCC-CORP expands the NCORP network by 6.5M people; with a higher cancer incidence rate than the US as a whole (477.5 vs 441.2 cases per 100,000). Regions of AHCC-CORP are even further elevated.

Public health relevance
PROJECT NARRATIVE The wide geographic and socioeconomic reach of AHCC-NCORP is crucial to the present and future health of New Jersey residents. Through AHCC-CORP, national NCORP research base-driven programs and unique research trials enable this state’s residents to participate in transformative clinical research from cancer prevention and screening through novel treatments, supportive care and ultimately survivorship. That’s the goal: to hopefully prevent but ultimately cure cancer.